Effects of Successful OSA TreatmENT on Memory and AD BIomarkers in Older AduLts (ESSENTIAL)

The prevalence of Alzheimer disease (AD) is high and projected to increase. Further, epidemiological data
suggests that ~15% of AD risk may be attributed to sleep problems. Obstructive sleep apnea (OSA) is also
common among the elderly (30-55%), and our prior work has established that cognitively normal older women
with OSA have nearly double the 5-year risk of developing mild cognitive impairment (MCI) or dementia.
Further, we showed that: i. OSA patients treated with positive airway pressure (PAP) experienced significant
overnight increases in plasma neurofilament light (NfL), a marker of neural injury, with strong trends for AD-
specific biomarkers (i.e. Aβ40 and Tau) after PAP withdrawal; ii. OSA predicted longitudinal increases in AD
biomarkers; and, iii. PAP treatment delayed the onset of MCI in subjects with reported OSA. There is therefore
strong evidence suggesting that OSA treatment could be an important prevention strategy for AD. However,
trials for treatment of OSA to slow cognitive decline and progression to AD face a number of challenges. First,
the most effective therapy (PAP) has poor adherence. A second challenge is defining the target population:
prior trials targeted OSA patients with MCI/AD, who have more advanced disease and could be less amenable
to treatment. A third challenge is identifying cognitive testing that is sensitive to sleep disruption, and linked to
increased AD risk. (To capture effects of OSA on the offline processing phase requires sleep-dependent
memory paradigms, in which the encoding and recall of information are separated by a period of sleep
with/without OSA). Finally, a randomized trial of sufficient duration to test the effects of treatment of OSA on
risk of incident AD is not feasible. Our proposed trial, Effects of Successful OSA TreatmENT on Memory and
AD BIomarkers in Older AduLts (ESSENTIAL), addresses these challenges. ESSENTIAL is a 5-year study of
cognitively normal older adults with newly diagnosed OSA, ages 55-75, recruited from 4 well-established sleep
clinics. OSA patients (n=200) will be randomized to either: i) a 3-month OSA treatment by any combination of
PAP, OAT, and positional therapy that results in an “effective” improvement in the apnea-hypopnea index
(AHI); ii) a waitlist control group to receive treatment at the conclusion of the 3-month intervention period.
Effectively treated individuals (~150) and untreated individuals (~100) will then be followed for up to 24 months
to compare whether sustained improvements in AHI are associated with better cognitive function and AD
biomarker change profiles as compared to untreated controls. Participants will undergo PSG, actigraphy,
cognitive tests, and blood draws at baseline, 3 and 24 months. Our aims are: 1) To compare 3-month change
in plasma AD biomarkers (NfL, p-tau, Aβ) between those randomized to OSA treatment and wait-list control
groups; 2) To compare 3-month change in cognition between the OSA treatment and wait-list control groups;
3) To examine if sustained reduction in AHI over 24 months among effectively treated participants versus
untreated controls is associated with better 24-month change profiles for AD biomarkers and cognition.

Public health relevance
The prevalence of Alzheimer disease (AD) is high and projected to increase. Obstructive sleep apnea (OSA) is common among the elderly (30-55%), and we and others have shown that older adults with OSA are at increased risk for dementia and AD. We propose a novel and flexible approach to treating OSA in cognitively normal older adults, and will test whether those successfully treated for OSA have slower decline in cognitive function, and improved AD biomarkers (measured in blood) compared to those who are untreated.